Immunometabolic Mechanisms of Protection against Infection

Immunometabolic Mechanisms of Protection against Infection
The NIMML Institute is a 501 (c) (3) non-profit public foundation focused on a transdisciplinary, team-science
approach to precision medicine at the interface of immunology, inflammation, and metabolism. We are
pioneering fundamental research on novel immunometabolic mechanisms that control disease severity and
treatment outcomes in infectious and autoimmune diseases. Clostridioides difficile is a spore-forming, toxin
producing, anerobic, gram-positive bacterium that causes nosocomial infectious colitis affecting almost half a
million people only in the U.S. yearly. There is an unmet clinical need for the development of antimicrobial-free,
host-centered therapeutics with increased efficacy to treat C. difficile infection (CDI). C. difficile toxins are the
main virulence factors of C.difficile. Immunometabolic mechanisms are implicated in modulating signaling
pathways and endosomal transport within the cell. During CDI, upon endocytosis and pH-dependent
translocation to the cytosol, activated TcdA and TcdB glucosylate and inactivate Rho GTPases. Preliminary
findings demonstrate that cytopathic effects, including inflammasome activation, cell death, and impaired barrier
function, are significantly suppressed by activation of novel immunometabolic pathways during intoxication.
This R21 aims to elucidate novel immunometabolic mechanisms that intercept bacterial toxin internalization and
processing to suppress cell damage. The specific Aims are:
AIM 1. To elucidate novel immunometabolic mechanisms that interfere with TcdA and TcdB
glucosylation of RhoA and Rac1 in colonic epithelial cells. We will use human intestinal organoids to
investigate whether immunometabolic pathways suppress glucosylation of Rho family proteins. We will link the
degree of glucosylation to induced cytopathic effects and their modulation through activation of immunometabolic
intervention.
AIM 2. To determine the role of a novel immunometabolic pathway in regulating endosomal pH and toxin
translocation in colonic epithelial cells: using colon-derived organoids, we will evaluate changes in
endosomal pH, V-ATPase activity and cellular sublocalization, and downstream signaling in response to
immunometabolic pathway activation.
This R21 grant application will investigate a novel immunometabolic mechanism that modulates the outcome of
bacterial intoxication. The results from these studies will provide the novel mechanistic insights to guide the
development of new host-based therapies targeting a new mechanism of action to treat CDI and other toxin-
producing bacteria.

Public health relevance
PROJECT NARRATIVE Clostridioides difficile is an opportunistic bacterium that colonizes the gastrointestinal tract upon gut microbiome disruption and can cause severe infections affecting almost half a million people every year in the U.S. The main virulence factors of C. difficile are toxins A (TcdA) and B (TcdB) which cause inflammasome activation, cell apoptosis and increased epithelium barrier permeability, leading to the induction of a strong immune response. This R21 proposal plans to elucidate novel broad-based immunometabolic mechanisms that might provide protection against intoxication of epithelial cells with TcdA and TcdB and potentially applicable to other toxin- forming bacteria.